Disrupted sleep architecture in adolescents with functional abdominal pain disorders

Project Summary
Functional abdominal pain disorders (FAPD) constitute one of the most common pediatric chronic pain
conditions. FAPD is associated with significant disability, school absenteeism and suboptimal treatment
outcomes. Treatment is hampered by an incomplete understanding of contributing factors like sleep
disturbances. Subjective sleep disturbances have been reported in FAPD but the role of sleep architecture and
its relationship to gastrointestinal (GI) symptoms has not been established. Preliminary data by the candidate
has shown decreased slow wave sleep (%NREM3) measured via polysomnography (PSG) in FAPD patients
vs. controls. Percutaneous Electrical Nerve Field Stimulation (PENFS) is an FDA cleared therapy for pediatric
FAPD. Preliminary data indicates that PENFS improves sleep in addition to symptoms of FAPD. However,
there is limited data on factors predicting response, effects on sleep architecture and underlying mechanisms.
The primary aims of this K23 training application are to:
(1) Determine the relationship of sleep architecture (NREM3 and other variables measured via PSG) with
abdominal pain and other patient-reported outcomes in a case-control study of adolescents with FAPD.
(2) Compare changes in sleep architecture before and after PENFS, associate with patient reported outcomes.
This is the first study to objectively characterize sleep architecture in pediatric FAPD and changes with PENFS.
Comprehensive measures of sleep physiology such as sleep questionnaires, daily diaries and actigraphy will
be employed in addition to PSG to associate with GI measures. The primary objective is for the candidate to
acquire advanced research training through a Master of Science in Clinical and Translational Research, learn
sleep (PSG and actigraphy) and pain assessments, and advanced statistical methods. The long-term goal is to
build an independent research program to study risk factors in pediatric FAPD and identify novel treatment
targets to improve outcomes. The K23 candidate is an Assistant Professor of Pediatrics, and a pediatric
gastroenterologist at Cincinnati Children's Hospital Medical Center (CCHMC). This application integrates a
thoughtfully designed research and training plan developed in conjunction with mentors and collaborators who
are leading scientists and clinical experts in pain, GI, sleep and behavioral medicine. CCHMC provides a rich
collaborative research environment and is deeply dedicated to the development of young investigators with
significant institutional funding opportunities, support in developing clinical trials, study monitoring, and
statistical analysis through core resources at the Digestive Health Center, and Clinical Translation Research
Center. This environment will be conducive to the candidate to complete the proposed research and training to
achieve full research independence. Results will build the foundation for a subsequent R01 trial to further
optimize PENFS outcomes and determine the relationship of central pain processing with NREM3 sleep.

Public health relevance
Project Narrative: Functional abdominal pain disorders (FAPD), one of the most common chronic pain conditions are associated with significant disability, school absenteeism and suboptimal outcomes. Improved treatment strategies are urgently needed but hampered by an incomplete understanding of contributing factors like sleep disturbances. Objectively characterizing sleep architecture through polysomnography in relation to gastrointestinal symptoms will pave the way for newer treatment targets modulating sleep or optimize existing treatments like percutaneous electrical nerve field stimulation to improve clinical outcomes.